Elucidating Cholinergic Relationships with Psychosis And Cognitive Deficits in Schizophrenia

PROJECT SUMMARY / ABSTRACT
Schizophrenia (SCZ) is among the most severe and disabling medical conditions worldwide, yet the brain alterations
that lead to the symptoms of SCZ remain unknown and the treatments are currently limited to dopaminergic (D2
receptor modulating) medications for their antipsychotic properties. Antipsychotic medications have incomplete efficacy
and carry a substantial side effect burden. There is thus an imperative to characterize non-dopaminergic markers to
guide diagnosis and treatment of SCZ.
One such promising marker to explore is the vesicular acetylcholinergic transporter (VAChT), levels of which provide
a critical indicator of cholinergic terminal activity in the brain. Although the pathophysiology by which the cholinergic
system may mediate SCZ symptoms is unclear, an increasing body of evidence suggests that presynaptic cholinergic
transmission may be involved in multiple disabling features of SCZ and new drugs directed at presynaptic cholinergic
activity show promise in the treatment of SCZ, including an M1/M4 muscarinic agonist therapeutic in Phase 3 trials which
was recently reported to be effective in significantly reducing positive and negative symptoms of psychosis, and
improving cognitive impairment, in patients with SCZ. We have exciting preliminary data using a new radiotracer that
targets VAChT ([18F]-VAT) with positron emission tomography (PET) imaging suggesting that cortical, hippocampal, and
thalamic VAChT strongly relates to positive psychotic symptoms and working memory deficits in patients with SCZ.
The proposed 5-year R01 study aims to replicate and extend these observations relating in vivo cholinergic
transmission to two of the most disabling features of SCZ. We will measure VAChT using PET with [18F]-VAT VT in a new,
larger sample of 40 patients with SCZ – 20 patients on antipsychotic medication and 20 unmedicated patients – and 20
healthy controls; and examine VAChT’s relationships among and within groups with clinical pathology.
If replicated and substantiated in a larger cohort, VAChT could be a reliable biological indicator of multiple key
features of SCZ that may serve as a marker of illness severity and a potentially valuable tool for the development of
biomarkers for diagnosis and treatment of SCZ.

Public health relevance
PROJECT NARRATIVE Results from this study will inform the suitability of VAChT as a candidate biomarker for severity of schizophrenia. This would be applicable to measuring severity of psychotic or cognitive deficits in patients with schizophrenia, and may be useful in diagnostic subtyping of patients with cholinergic system alterations whose symptoms could be responsive to cholinergic-modulating treatments. The data gleaned from this study will also be critical information in further elucidating underlying pathophysiology of symptoms of schizophrenia and in guiding future studies of treatment efficacy and therapeutics development.